BIOCURRENTS WEBSITE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. With the evolution of the Center's activities and technology, there has been a great need for a restructured BRC website- and one requirement from the last renewal was to produce a new site. Our goals during the site's creation were to enhance the education and dissemination component and to highlight the unique biomedical applications of the Center. The design, structure and organization were re-evaluated and re-designed to allow for ease of navigation and straightforward accessibility of information.